NEXT DTP-22-018, GMP PRODUCTION OF 40 MG Z-ENDOXIFEN (NSC 774768) CAPSULES

NEXT DTP-22-018, GMP PRODUCTION OF 40 MG Z-ENDOXIFEN (NSC 774768) CAPSULES CONTRACT/TO#DCTD-2022-1007 DEVELOPMENT & MANUFACTURE OF ORAL & TOPICAL DOSAGE